Novel Therapeutic Approach to Hypercholesterolemia Using Anti-PCSK9 Selected Immune Repertoires

? DESCRIPTION (provided by applicant): We have developed and completed a proof-of-principle on a new transgenic mouse model for comprehensive characterization of the antibody repertoire made in response to PCSK9 injection, and have identified a set of high affinity neutralizing antibodies which will be tested in animals for efficacy and potency.

Public health relevance
PUBLIC HEALTH RELEVANCE: Therapeutic and diagnostic applications of monoclonal antibodies (mAbs) offer a way to target treatments to specific proteins. However, monoclonal antibodies have traditionally been made using hybridoma technologies which only access a small fraction of the immune system. Abeome has developed a novel method of antibody discovery using direct sorting of antigen- specific antibody producing cells. Thus, the immediate goal for this Phase 2 project is to test and improve Abeome's newly discovered antibodies that neutralize the PCSK9/LDLR interaction in animals to determine their efficacy and potency. Our ultimate goal is to develop an immuno- therapeutic for the treatment of hypercholesterolemia and to partner the technology with pharmaceutical/biotechnology companies.